Research Education Core

Project Summary/Abstract: RESEARCH EDUCATION COMPONENT
needs of older adults with serious illness (OASI) and their families. This proposal for the Research Education
Component (REC) of our OAIC aims to develop research leaders through creation of a dedicated program of
academic and research development for junior investigators in geriatric palliative care (GPC) research,
encompassing researchers from a broad range of clinical and social science disciplines. The ultimate goal of
the REC is to provide a strong foundation in the fundamentals of research for OASI and place these scientists
on a path to obtaining external funding and ultimately research independence. In this proposal we have
outlined a detailed plan to recruit talented early-stage scientists from diverse disciplines and provide them with
advanced training in research methodology including expertise in dementia, health disparities research and
implementation science, an individualized career development plan, relationships with experienced mentors,
assistance in accessing the OAIC’s three resource cores, and support to conduct research studies focused on
OASI. Candidates for this core include individuals who are immediately out of training and are starting a
research path or are career switching from a clinical career to a research career (“very early investigators”);
investigators who are preparing for or are in the process of submitting an NIH or foundation career
development award (“pre-K” stage); and scientists who are transitioning off a career development award and
need additional support as they apply for R01 grants or equivalent mechanisms (“K to R”). The curriculum for
the REC scholars consists of two core elements designed to efficiently leverage OAIC and institutional
resources. One element is a core curriculum in research design, methods and statistics offered by Mount
Sinai’s Graduate School. The other element is a curriculum addressing elements related to specifically to GPC
research that has been developed by OAIC faculty; this curriculum includes our cross-cutting themes of
dementia and implementation science research, and new to this renewal – health disparities research. Training
and weekly mentoring will occur in a variety of venues and will include clear roles and responsibilities for REC
scholars and mentors alike. We have incorporated the use of individualized career development plans and
project tracking grids that infuse a spirit of accountability and provide a structure for monitoring progress.
Regular and rigorous evaluation of scholars as well as the program is in place. Oversight assures that the
core’s co-leaders interact on a regular basis with other OAIC leaders as member of the Leadership and
Administrative Core and of the Executive Committee, ensuring that the REC is successful. Additionally, the
OAIC Scientific Advisory Council (SAC) will provide oversight to the REC, review all REC proposals, and make
funding decisions. The SAC will work with the REC leaders to assure that the core creates a group of wellsupported
and well-trained junior investigators dedicated to improving the care of OASI and their families.